National Consortium on Alcohol and NeuroDevelopment in Adolescence (NCANDA): Administrative Resource

PROJECT SUMMARY
Initiating excessive alcohol drinking during adolescence is known to disturb typical neurodevelopment, increase
the risk of alcohol use disorder (AUD), and accelerate involutional processes in adulthood. This application
proposes examination of socioeconomic status (SES) and racial/ethnic differences in the Recovery specialty
project of the National Consortium on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-
A). The Recovery Project at the Duke, OHSU, and UCSD Research Sites examines the extent to which short-
term (i.e., 4 weeks) alcohol use discontinuation results in acute improvement in cognition, affect, sleep and
resting heart rate, and reversal of the adverse structural and functional brain effects of frequent binge alcohol
use. For this application, we will extend analyses planned in the parent grant with supplemental analyses of
patterns and predictors of abstinence and changes in behavior for adolescents and young adults participating in
the four-week abstinence protocol who identify as from diverse socioeconomic and minoritized ethnic/radial
backgrounds. We will test the hypothesis that predictors of recovery after 4 weeks of discontinuation of alcohol
consumption, and predictors of improvements in behavior and affect during this time, will differ by SES and
ethnic/racial group. The study has two specific aims. Aim 1 will investigate how four weeks of abstinence
influence mental health (depression and anxiety), physical activity level, social interaction, and self-reported
sleep as a function of socioeconomic indicators and racial/ethnic group. Aim 2 will examine cultural, community,
and context predictors of abstinence and improvements by SES and racial/ethnic group. Analyses within the
Recovery Project will serve as pilot research to assist the candidate in understanding the social determinants of
these aspects of health. A “Research Independence Plan” is proposed to shape the candidate’s future goals and
professional development during the training period through weekly meetings with Dr. Sandra Brown, guided
readings, and supervised writing, data analysis and scientific dissemination. The trainee will work with the
NCANDA research team at UC San Diego to learn the Recovery protocol, attend biweekly seminars on
substance use research with adolescents, and receive professional development mentorship with Dr. Brown in
weekly meetings, including the responsible conduct of research.

Public health relevance
PROJECT NARRATIVE This diversity supplement to the parent grant, the National Consortium on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-A): Administrative Resource (U24 AA021695), will extend analyses to patterns and predictors of abstinence and changes in behavior within minority adolescents and young adults participating in the four-week monitored abstinence Recovery protocol. Analysis of social determinants of behavioral and mental health outcomes for young adults able to abstain from alcohol for a month will assist in understanding potential differences across socioeconomic status and race/ ethnic groups.